Regulation of oncogenic Akt ubiquitination and activation by diverse mechanisms in cancer

Summary
The PI3K/Akt signaling is one of most important oncogenic events in human cancers. It regulates many aspects
of biological functions including cell proliferation, survival, and metabolism important for cancer initiation and
progression. While extensive efforts have been made in the last three decades to understand the downstream
effectors responsible for the biological and oncogenic processes regulated by PI3K/Akt signaling, the upstream
signals mediating PI3K/Akt signaling activation upon diverse growth factor stimulation is not well understood.
Understanding and defining the upstream mechanisms responsible for PI3K/Akt signaling activation will not
only provide new insight into how PI3K/Akt signaling activation is orchestrated, but also offer novel paradigms
and therapeutic targets for cancer intervention. Although it has been well established that PIP3 is critical for
the membrane recruitment and subsequent activation of Akt, our recent studies provide the evidence that Akt
undergoes methylation and subsequent non-proteolytic K63-linked ubiquitination, which are crucial for Akt
membrane recruitment and subsequent phosphorylation and activation upon stimulation with diverse growth
factors, opening up a new frontier for Akt signaling regulation. Of note, we identified SETDB1 as a
methyltransferase for Akt K64 methylation and TRAF6 ligase as an upstream E3 ligase triggering K63-linked
ubiquitination and activation of Akt, and these events are required for cancer progression. However, the
outstanding questions remained to be addressed are how SETDB1 and TRAF6 are activated or recruited to the
Akt complex upon growth factor treatment to trigger Akt methylation and subsequent Akt ubiquitination and
activation, thus promoting oncogenic processes. The goal of this study is to dissect the upstream regulatory
mechanisms by which growth factors activate and recruit SETDB1 and TRAF6 ligase to Akt complex to elicit
Akt methylation and subsequent Akt ubiquitination, define the mechanism by which Akt ubiquitination
facilitates Akt membrane localization and activation, and finally explore the role of these regulatory modes in
cancer development and develop small molecule inhibitors targeting these regulatory mechanisms. Our
preliminary results revealed that SETDB1 and TRAF6 undergo novel posttranslational modifications, which are
crucial for methylation, ubiquitination and activation of Akt by growth factors and oncogenic activity. We
hypothesized that SETDB1 and TRAF6 undergo the novel posttranslational modification upon growth factor
treatment, which recruits SETDB1 to the Akt complex and activates TRAF6 E3 ligase to facilitate Akt
methylation and subsequent Akt ubiquitination and activation, thus leading to tumorigenesis. Our innovative
hypothesis has been formulated based on our preliminary results and prior research. We proposed three
specific aims to validate this provocative and paradigm-shifting concept using cutting-edge technologies
including xenograft, organoids from genetic mouse tumor models and patient derived tumors, patient-derived
models (PDX), knockin mouse models, genetic mouse tumor models and pharmacological approaches. This
application is significant, therefore, because it is expected to provide the knowledge needed to develop
pharmacologic strategies that will allow concurring cancers with aberrant PI3K/Akt activation. Our study will
open up a new avenue for PI3K/Akt signaling regulation, but also offer new concepts and strategies for cancer
targeting.

Public health relevance
Narrative The PI3K/Akt signaling is one of most important oncogenic events in human cancers, which regulates many aspects of biological functions including cell proliferation, survival, and metabolism important for cancer initiation and progression. The objectives of this study are to dissect the upstream regulatory mechanisms by which growth factors activate and recruit SETDB1 and E3 ligases TRAF6 to elicit Akt methylation and subsequent K63-linked ubiquitination, to understand how Akt ubiquitination triggers Akt membrane recruitment and activation, and to explore these regulatory mechanisms and its targeting in oncogenic processes. Our study represents a highly innovative and paradigm-shift proposal that will not only open up a new avenue for PI3K/Akt signaling regulation, but also offer new concepts and strategies for cancer targeting.